A novel regulator of Ca2+ homeostasis and arrhythmia susceptibility

PROJECT ABSTRACT
Atrial fibrillation (AF) is the most common clinical cardiac arrhythmia, with a strong component of heritability.
Patients with AF are at significant risk for debilitating complications, such as stroke, heart failure and sudden
death. Emerging evidence suggests that both common and rare genetic variants in cardiac transcription factors
contribute to AF susceptibility. This link between transcription factors and AF offers exciting opportunities to
investigate previously unrecognized pathways to identify novel “upstream” therapeutic targets. We recently
identified the cardiac transcription factor NFATC1 as a novel AF susceptibility gene in a family with autosomal
dominant young-onset AF. The overall goal of this proposal is to explore the molecular and electrophysiological
role of NFATC1 in cardiac excitability. Our central hypothesis is that NFATC1 directly regulates genes involved
in maintaining calcium homeostasis in the atrium. We proposed three specific aims to test this hypothesis: (1)
identify NFATC1 transcriptional effectors linked to calcium homeostasis in atria; (2) establish the
electrophysiological consequences of NFATC1 disruption in atrial cells; and (3) define NFATC1 modulation of
adrenergic signaling in the heart. The output of this project will be a comprehensive understanding of the
transcriptional networks mediated by NFATC1 that impact calcium homeostasis and promote arrhythmogenesis,
laying the foundation for potential future therapies.
The research activities proposed in this career mentored award will provide experiential learning in support of
my career development objectives. These include (1) expanding my skills into genomics research, optical
mapping and new animal models that are more suitable for the study of arrhythmias, (2) strengthen my research
leadership and management skills, and (3) enhance my grantsmanship to secure independent funding.
Achieving these goals will allow me to develop a research career as an independent principal investigator of a
multidisciplinary cardiovascular research lab that makes substantial contributions to understanding the
development of heart disease.

Public health relevance
PROJECT NARATIVE Atrial Fibrillation is the most common type of cardiac arrhythmia in clinical practice, with a projected rise in prevalence and increased economic burden due to its complications. Our proposed studies will help determine how transcription factors regulate cardiac excitability, advancing our mechanistic understanding of the genetic susceptibility to cardiac arrhythmias. This project is relevant to the NIH mission because it will lay the foundation for future development of new therapeutic approaches to atrial fibrillation